Rapid and high-contrast photothermal microscopy with a novel tunable ZGP source

Abstract.
Natural products offer excellent sources of health-promoting medicines yet challenges in
efficiently and economically sourcing these value-add bio-compounds have prevented their
greater availability and promotion to public health. We address this problem by developing a novel
image-based screening technology that offers highly sensitive, phenotypic bioassays of
metabolite concentrations on live single cells. This allows a greatly improved method for
identification of better natural product producers, as well as quantitative information about the
production per cell and production distribution across the population. This high-resolution, non-
destructive, label-free cell screening and cell sorting system is based on vibrational photothermal
microscopy which uses mid-infrared light to probe molecular vibrational absorptions at resolutions
comparable to visible light microscopes. To demonstrate the utility of the approach we focus on
the production of essential polyunsaturated fatty acids (PUFAs) in lipid droplets sourced from
microalgae (thraustochytrids) – a natural producer of PUFAs. These long-chain fatty acids play a
vital role in the physiological health of cells and tissues throughout the body are commercialized
as a prominent nutraceutical. To develop enriched cell lines, we will engineer and prototype a
multichannel microfluidic chip with an active piezoelectric actuator to selectively save cells
identified through photothermal as being highly productive. Our goal is to provide an attractive
method to non-destructively evaluate metabolite content in engineered microbes including
bacteria and yeast, not just algae, and for a variety of high-value metabolites. To accomplish
these goals, we have established a team of qualified experts including specialists in advanced
microscopy, microfluidics design, and algae cultivation for industrial applications. Ultimately, the
methods developed here will showcase a roadmap toward rare-cell discovery and active cell
sorting based on chemical mapping allowed through the photothermal imaging contrast.

Public health relevance
Project Narrative. Development of a broadly tunable mid-infrared light source with high pulse energy and narrow linewidth is essential to generate strong signals through vibrational photothermal imaging. Such an optimized light source would bring this nascent imaging modality to the forefront of biomedical imaging of single-cells and tissue biopsies by enabling true chemical mapping at much higher throughput than methods reliant on legacy IR light sources. Here, to support such innovation, we unite a team of expert microscopists and laser development researchers to prototype and characterize performance of such a light source for the purpose of generating high-resolution, hyperspectral data cubes with chemical information throughout the IR-fingerprint region.